A Targeted Approach to Treat Immunotherapy-Induced Myocarditis with CXCR3 Blockade

PROJECT SUMMARY/ABSTRACT
Immune checkpoint inhibitors (ICIs) are cancer therapeutics that unleash T-cell cytotoxicity against tumors. While
effective for up to 50% of cancer patients, ICIs can cause ICI myocarditis (ICIM), pathologic inflammation of the
heart—a life-threatening side effect leading to arrhythmias, heart failure and death. Despite a high case fatality
rate, there are no effective ICIM therapies; thus, there is an enormous unmet clinical need for mitigating therapies.
Our group has defined immunologic drivers in ICIM using pre-clinical and patient samples. Using novel single-
cell multi-omics, we found that crosstalk between T-cells and macrophages in the heart is critical for ICIM
development, bringing forth a new therapeutic opportunity. This proposal is to develop a mechanism-based
therapy for ICIM blocking crosstalk between macrophages expressing chemokines CXCL9/10
(CXCL9/10+MP) and antigen-specific T-cells expressing the chemokine receptor CXCR3 (CXCR3hiCD8
T-cells) in the heart. Our previous work has shown that CXCR3 blockade mitigates ICIM in a non-tumor mouse
model. Since current ICIM models do not account for tumor, we have now created more realistic tumor ICIM
models by inoculating C57/BL6J mice with B16F1 melanoma/MC38 colorectal tumors. Our preliminary data in
these models demonstrate mitigation of ICIM with CXCR3 blockade while maintaining ICI tumor control. Through
drug screening, we have discovered drug-like small molecule CXCR3 inhibitors which will increase translational
opportunities. In Aim 1, we will test the hypothesis that ICIM involves a cardiac infiltration of
CXCL9/10+MP/antigen-specific CXCR3hiCD8+ T-cells in ICIM distinct from tumor associated macrophages
(TAMs)/antigen-specific CD8 tumor infiltrating lymphocytes (CD8 TILs) present in tumors. We will validate our
findings in our tumor mouse models and patient samples. In Aim 2, we will perform CXCR3 blockade in the
mouse tumor models, assessing the effect of blockade on heart/tumor phenotype and immune profile using
single-cell multi-omics. In Aim 3, we will test the hypothesis that CXCR3 blockade reduces migration/cytotoxicity
of cardiac CXCR3hiCD8 T-cells but not CD8 TILs. We will determine functional effects of CXCR3 blockade on
cardiac CXCR3hiCD8 T-cell/TIL ex vivo with transwell assays and co-cultures with cardiomyocytes/tumor cells.
These studies will provide critical and timely data on CXCR3 blockade as a novel targeted therapy for ICI
myocarditis in a clinical space where treatments are urgently needed.

Public health relevance
PROJECT NARRATIVE Myocarditis, a serious inflammatory reaction in the heart causing cardiac death, can occur as a result of immunotherapy used to treat cancer. Unfortunately, there are currently no effective medical therapies for this type of myocarditis. This project aims to test and validate a novel drug target on T-cells in the heart—called CXCR3—using mouse models and tissue samples collected from patients with this disease, thus helping to ensure cardiovascular safety for cancer patients.